Collagen Proteostasis in Health and Disease

Collagen is the most abundant protein in animals, constituting up to one-third of total protein in humans.
As the major proteinaceous component of tissues ranging from bone and skin to cartilage and basement mem-
branes, it constitutes the molecular scaffold for animal life. This ubiquitous protein is uniquely challenging for
cells to produce, requiring highly coordinated intracellular processes of synthesis, folding, assembly, and qual-
ity control. Owing to the hierarchical nature of collagenous extracellular matrices, the physical and biochemical
properties of such tissues are fundamentally defined by these upstream, intracellular processes. Defects,
whether genetic or otherwise, that are detrimental to any aspect of collagen proteostasis can impact the health
or function of collagen-producing cells and also propagate to extracellular matrices, leading to diseases known
as the collagenopathies. Unfortunately, these diseases almost universally lack effective, disease-modifying
therapies.
Current therapeutic approaches to the collagenopathies focus on regenerative interventions, efforts to
strengthen the extracellular matrix itself, or palliative care. None of these strategies aims to address the up-
stream issue leading to disease: a failure to properly fold and quality control collagen molecules themselves. If
the breakdown of collagen proteostasis could be effectively addressed, the downstream symptoms targeted by
current clinical strategies would be alleviated. Indeed, proteostasis enhancement has proven remarkably effi-
cacious in many other genetic disorders, including cystic fibrosis, but it has yet to make serious inroads in the
collagenopathies. One obstacle is inadequate understanding of the critical decision points in the collagen pro-
teostasis network. Another issue is the challenge of pre-clinical testing of proteostasis-targeted interventions in
a disease that requires robust, yet biochemically amenable, tissue model systems for discovery efforts.
This R01 proposal seeks to address these knowledge gaps, both identifying and elucidating key mech-
anisms of intracellular folding and quality control, and assessing the therapeutic potential of proteostasis net-
work-targeted interventions in the collagenopathies. In Aim 1, functions of the highly conserved procollagen N-
glycan in promoting folding, enabling quality control, and identifying when folded procollagens are ready for
secretion will be elucidated, via comprehensive work both in cells and in vivo that will reveal the molecular
mechanisms of collagen glycoproteostasis. The expectation is to demonstrate that the long-ignored procolla-
gen N-glycan is actually the critical fulcrum of collagen proteostasis. In Aim 2, a state-of-the-art, 3D cartilage-
in-a-dish model system is deployed to enable robust testing of proteostasis network-targeted therapies for the
collagenopathies. Combined with mechanistic studies to elucidate the biochemistry of dysregulated collagen
proteostasis, work in this Aim will provide a strong foundation for a new, proteostasis-focused perspective on
treating the collagenopathies.

Public health relevance
Proper synthesis, folding, modification, assembly, and quality control of collagen, the most abundant protein in the human body, is essential for the structure and function of diverse tissues, including bone, skin, cartilage, tendon, and more. Defects in collagen production underlie diverse, currently incurable diseases. This proposal (1) uses a comprehensive suite of in vitro and in vivo approaches to elucidate molecular mechanisms of collagen production, both how they work well and how they go awry, and (2) tests new, small molecule- based strategies for ameliorating disease-causing collagen proteostasis defects in state-of-the-art 3D tissue model systems, culminating in advances in fundamental understanding and new therapeutic approaches for the collagenopathies.